K9-ICT: A Novel Urethral Valve Treatment for Canine Urinary Incontinence

Project Summary / Abstract
Venarum Medical, LLC (Venarum) is developing the Canine INCONTrol Urethral Valve System (K9-ICT), a
novel urethral implant solution for the treatment of urinary incontinence (UI). This transurethral, catheter-
delivered valve is intended to control the flow of urine in order to reduce urine leakage and other complications
of UI. It consists of a Nitinol scaffold embedded in a biocompatible polymer with a completely integrated
polymeric inner valve which is comprised of a flexible leaflet-like membrane. The K9-ICT valve is placed in the
mid to proximal urethra and is designed to significantly reduce urine leakage by restoring the ability to retain
urine and void at similar urinary bladder pressures that are seen in continent dogs. Added during Phase I, the
valve will also be retrievable to mitigate potential adverse reactions and/or poor placement. This Phase II
objective is to demonstrate preliminary clinical safety of the final K9-ICT.
Canine UI is a condition characterized by inappropriate or “involuntary” passage of urine. Clinical signs and
sequelae of UI include urine leakage, unwanted urination in the house, skin irritation, and discomfort. The most
common non-neurogenic cause of canine UI is urethral sphincter mechanism incompetence (USMI), which is
thought to be hormone-related and affects over 20% of spayed female dogs, equating to roughly 5 million pets
in the U.S. None of the current treatment options for UI—medical management, urethral bulking agents, and
surgical correction—are reliably efficacious and all carry risks.
Venarum intends to leverage its expertise in implantable device technologies, veterinary medicine and polymer
science to bring the K9-ICT from concept to market. We have extensive experience with polymer-coated Nitinol
stent technology through the ongoing development of a prosthetic venous valve and are well positioned to apply
our design and manufacturing knowledge to meet the unique challenge of canine UI. Effective treatment of UI
requires an understanding of the interplay between intra-abdominal pressure, urinary bladder pressure,
urethral pressure, sphincter competency, and the feedback and reflexes involved in the voiding mechanism.
Through bench and cadaver studies in Phase I, Venarum has demonstrated that the valve can easily be delivered;
can feasibly prevent indiscriminate fluid leakage and permit fluid passage within a desired range of pressures
approximating those in continent dogs; and can be retrieved.
Under Phase II, Venarum proposes to (1) optimize and finalize the system components (i.e. valve, delivery
system, and retrieval tool); (2) perform physical and biocompatibility verification testing of the final K9-ICT
system; and (3) perform in vivo canine clinical preliminary safety studies consistent with evaluations of devices
intended for human use. Venarum will continue to engage the veterinary community and canine UI experts in
order to build interest in the K9-ICT technology and identify an efficient path to commercialization.

Public health relevance
Project Narrative Canine urinary incontinence (UI), most commonly caused by urethral sphincter mechanism incompetence (USMI), affects millions of dogs in the United States. Signs associated with UI such as urine dribbling, house soiling, and skin irritation can profoundly and negatively impact the quality of life of canine pets and their owners. Venarum’s proposed implantable urethral valve system controls urine flow, which could enable a treatment option for canine UI that does not exist today and may contribute to an improvement in technical and medical knowledge of UI management.